Home Based Rehabilitation for COPD

PROJECT SUMMARY/ABSTRACT
Chronic obstructive pulmonary disease (COPD) is one of the main causes of morbidity and mortality
worldwide. Pulmonary rehabilitation (PR) is considered a critical part of COPD treatment, reducing
breathlessness, increasing health-related quality of life, and decreasing health care utilization. However, only a
small portion of patients with COPD access PR due to transportation issues, or the frailty of patients.
Home-based PR has been found useful, but has not been implemented due to the lack of available PR programs
and systems which continuously monitor the patient's safety and progress.
Self-management support (SM), as proposed in the chronic care model and in international COPD guidelines,
is not widely implemented. Pulmonary rehabilitation represents a unique opportunity for SM given the
meaningful engagement and communication existing with a care provider through the program.
In this application, we propose to test the effectiveness of a home-based PR system developed in our previous
research project which would make PR feasible in the patient's own home with accurate monitoring and
feedback and SM support through a health coach. The proposed system fills a knowledge/practice gap in COPD
care by increasing access to PR which may translate to improved well-being and heath care outcomes.
This simple, yet highly innovative home–based PR system which uses commercially available monitors will
promote higher adherence to PR and to SM support and lead to a sustained improvement of well-being.

Public health relevance
PROJECT NARRATIVE Pulmonary Rehabilitation (PR) is considered a critical part of chronic obstructive pulmonary disease (COPD) treatment, reducing breathlessness, increasing health-related quality of life, and decreasing health care utilization. However, only a small portion of patients with COPD access PR, most commonly due to transportation issues or frailty. In this application we propose to test the effectiveness of a home-based PR system plus health coaching that aims to improve quality of life, daily physical activity, and self-management.